Mentoring a Nigerian junior investigator with a mixed-methods analysis of barriers to colorectal cancer presentation in Nigeria

SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
22-036. This is an administrative supplement to our parent award R01 CA246620 (PI: Alatise/Du/Kingham)
focused on identifying risk factors for colorectal cancer (CRC) in Nigeria. Our work is motivated by the rapidly
rising incidence and mortality of CRC in sub-Saharan Africa. This increasing burden is mirrored in Nigeria, the
most populous country in Africa, where >50% of patients die within one year of diagnosis. These statistics
highlight the need for new prevention, screening, and treatment interventions tailored to this limited-resource
region. However, traditional risk factors that serve as a basis for CRC interventions are far less common in
Nigeria compared to Western populations. To better understand the unique risk factors of CRC, we are recruiting
600 CRC cases and 1,200 matched cancer-free population-based controls for a case-control study as part of
our ongoing parent R01. Participants complete a questionnaire to assess demographic, anthropometric,
reproductive, lifestyle, dietary, and medical history. We expect to obtain knowledge of CRC risk factors to identify
high-risk subgroups that can be targeted for screening and/or early detection. In addition, through this work, we
have built research capacity to facilitate complementary CRC studies. As such, the overarching goals for this
supplement are to strengthen capacity for high-quality research through mentorship of a promising junior
surgeon-scientist, and to generate evidence that will complement our R01 findings. Specifically in this
supplemental project, we will conduct a mixed-methods study to determine knowledge of CRC and barriers to
CRC early diagnosis in patients in Lagos, Nigeria. Patients ≥50 years of age (n=350) who are healthy controls
in our R01-funded case-control study will participate in quantitative assessment of knowledge of CRC symptoms
and treatments. For the qualitative phase, community-based focus groups in people without CRC and in-depth
one-on-one interviews with patients with CRC will be conducted. The study's key outcomes are knowledge of
CRC symptoms, CRC diagnosis practices, and barriers to CRC early diagnosis. We expect this supplemental
project to generate rich data that paired with our R01 findings can guide future improvements in CRC diagnosis
in Nigeria to ultimately improve treatment options and outcomes.

Public health relevance
NARRATIVE Our work is motivated by the rapidly rising incidence and mortality of colorectal cancer (CRC) in sub-Saharan Africa. Our overarching goals for this supplement are to strengthen capacity for high-quality research through mentorship of a promising junior surgeon-scientist, and to generate evidence that complements our parent R01 on identifying risk factors for CRC in Nigeria. Specifically in this supplement, we will conduct a mixed-methods study to determine knowledge of CRC and barriers to CRC early diagnosis in patients in Lagos, Nigeria.